Integrative Bioinformatics

The Integrative Bioinformatics (IB) Support Group provides specialized expertise in computational analysis and develops bioinformatics tools and resources to advance scientific research. Equipped with robust computational infrastructure and a comprehensive collection of bioinformatics software, the IB group excels in handling complex biological data. The group has extensive experience in managing and analyzing diverse experimental datasets including, but not limited to, NGS, single cell and multi-omics, spatial transcriptomics, microbiome, metabolomics and proteomics. In addition to direct data analysis, the group plays a key role in implementing standardized analytical pipelines, promoting best practices, and developing custom tools to enhance and facilitate intramural research and discovery.

Facilitating Scientific Research and Discovery:

The IB group provides comprehensive, collaborative bioinformatics support to research groups and core facilities, playing a vital role in advancing scientific discovery. During this reporting period, the IB group has actively worked with 42 research groups and 4 data-generating cores from NIEHS, along with six external research labs from UF, JHU, EPA, NHGRI and NIDDK. These collaborations resulted in 25 peer-reviewed publications in which the group members were co-authors. For a complete list of our collaborative publications and scientific contributions, please visit our PubMed collection at https://pubmed.ncbi.nlm.nih.gov/collections/61587586/?sort=pubdate.

Developing Innovative Analytical Tools:

The IB group is committed to continuously evaluating and enhancing our data analysis capabilities to meet the evolving scientific needs of the intramural research community. During this reporting period, we have made substantial progress by developing new analytical workflows and approaches that streamline complex data analysis. Notably, we have established SOPs for spatial transcriptomics, a valuable resource for the broader research community. In close collaboration with other research groups, we are actively working on developing single cell tools called GIBOOST to enhance visualization of complex high-dimensional data. The completed list of our development publications could be viewed at https://pubmed.ncbi.nlm.nih.gov/collections/61694443/?sort=pubdate.

Empowering Researchers Through Bioinformatics Training:

The IB group offers comprehensive training opportunities for scientists at all levels, with a strong focus on building bioinformatics skill among trainees, including post-docs, post-bacs, students, and interns. To achieve this goal, we have curated tutorials and workshops designed to empower participants with both foundational knowledge and practical, hands-on experience. In collaboration with the Biostatistics Branch, the IB group organized biannual short course series consisting of 12 courses, which were primarily attended by trainees. additionally, the IB group members provide on-demand, customized trainings for those individuals seeking advanced skills beyond standard analyses. These personalized sessions enable participants to explore cutting-edge bioinformatics methods and tackle complex analytical challenges.